ROLE OF ANGIOTENSIN-(1-7) AND DIAPHRAGM VASCULAR FUNCTION IN HEART FAILURE AND PROLONGED MECHANICAL VENTILATION

PROJECT SUMMARY
Heart disease is the leading cause of death in the United States. Diaphragm dysfunction is prevalent in
heart failure (HF) patients and both precedes and surpasses that seen in other locomotory skeletal muscles;
increasing susceptibility to respiratory muscle failure and exercise intolerance as well as predisposing these
patients to ventilator-induced diaphragmatic dysfunction (VIDD). Impaired vascular function is regularly present
in peripheral skeletal muscles with HF, compromising the blood flow and oxygen delivery required to support
contractile function. However, the role of diaphragm vascular dysfunction in HF-induced diaphragm fatigue,
and whether these changes in diaphragm vasomotor control are exacerbated with prolonged mechanical
ventilation (MV), often employed in this patient population, is not known. Further, cardiovascular dysfunction is
an important contributor to problematic weaning and increased mortality with MV. Prolonged MV in-and-of
itself elicits diaphragm vascular dysfunction, which contributes to weaning failure with MV. HF and MV patients
consistently exhibit increased renin-angiotensin system (RAS) activation and elevated levels of circulating
Angiotensin-II (Ang-II), which largely contributes to skeletal muscle vascular dysfunction as well as diaphragm
atrophy in both HF and prolonged MV. These findings suggest that HF patients are predisposed to more
pronounced MV-induced diaphragm vascular dysfunction.
Preliminary data supports that HF impairs endothelial-dependent vasorelaxation in diaphragm
arterioles, and the added insult of prolonged MV nearly abolishes endothelial-dependent vasorelaxation.
However, the impact of HF combined with prolonged MV on diaphragm blood flow and vasomotor control has
never been determined. Therefore, our global hypothesis is that diaphragm resistance vessel (i.e.
arterioles) function (e.g. endothelial-dependent vasorelaxation) is significantly diminished in HF and
exacerbated with MV. As such, pharmacologically counteracting the vascular effects of Ang-II will
improve diaphragm perfusion and preserve vascular function with prolonged MV and HF + prolonged
MV.
This project will be completed at Kansas State University (KSU) under the guidance of Drs. Bradley J.
Behnke and David C. Poole. The training plan has been formulated to facilitate the development of technical
proficiencies and critical thinking skills needed to execute the proposed experiments and incorporates the
elements essential for the applicant to transition into an independent scientific career. The Behnke and Poole
Laboratories, and the Departments of Kinesiology and Anatomy and Physiology at KSU represent a rich
scientific environment that will provide outstanding graduate training and a research opportunity to gain new
insights into diaphragm blood flow regulation and vasomotor control in healthy and diseased animal models.

Public health relevance
PROJECT NARRATIVE Diaphragm vascular dysfunction portends and contributes to the diaphragm atrophy and contractile dysfunction associated with prolonged mechanical ventilation (MV) and such diaphragm muscle abnormalities (e.g. atrophy, contractile dysfunction) are present in heart failure (HF), however, the role of diaphragm vascular dysfunction in HF, as well as the impact of HF with the added insult of prolonged MV on diaphragm vascular function, has never been investigated. Therefore, using a unique combination of techniques (fluorescent microspheres, isolated blood vessel preparation, contractility measures), the current proposal will determine the distribution of diaphragm blood flow and diaphragm vasomotor function in HF and HF + prolonged MV as well as the efficacy of pharmacological treatment (Angiotensin-(1-7)) to improve diaphragm blood flow, vascular function, and in vivo contractile function with prolonged MV and HF + prolonged MV rats. Diaphragm vascular function is a neglected field of research in both health and disease and yet preventing the harbingers of respiratory muscle failure, if possible, will do much to lessen the human burden of major pathologies such as HF and COVID-19.